Distributed dynamics & cognition in a large-scale primate cortical circuit model

Project Summary
The goal of this grant renewal is to develop theory and large-scale circuit modeling of the primate cortex
with many interconnected areas, for distributed working memory and flexible decision processes as well as its
dopamine modulation. This research program is designed to meet the challenge of understanding cognition
beyond local circuits towards the complex global brain. The proposed work is now feasible thanks to recently
available mesoscopic directed- and weighted data for inter-areal connections of macaque cortex. We have
already published several papers on the development of a large-scale, multi-regional dynamical cortical circuit
model of macaque monkey, including a population rate model endowed with a laminar cortical structure and a
spiking network model. Our computational work will be undertaken in collaborations with five experimental
labs working on macaque monkeys (Earl Miller (MIT), John Duncan (Oxford University, UK), Stefan Everling
(Western University, Ontario, Canada), Henry Kennedy (ISERM, Lyon, France) and Karl Zilles (Jülich
University, Germany)). Specific Aim 1 will be to build a large-scale cortical circuit model of
macaque monkey for distributed working memory. Hypothesis: distributed self-sustained activity
patterns underlying working memory depend on a combination of the mesoscopic inter-areal connection
properties and gradients of circuit properties across a brain’s hierarchy. Specific Aim 2 will be to
investigate high-dimensional dynamics of persistent activity underlying a high degree of
temporal variations. Hypothesis: NMDA/AMPA receptor ratio is higher at top-down projections than
bottom-up ones, and there is a macroscopic gradient of short-term plasticity. The two combined contribute to
complex spatiotemporal mnemonic neural population activity that is better described by trajectories in a
high-dimensional state space. Specific Aim 3 will be to expand the model to simulate decision-
making and rule-based flexible sensorimotor behavior. Hypothesis: the same model endowed with
different representations (spatial location, object features such as color and motion direction, rule encoding,
respectively) in different cortical areas can be used to simulate rule-based flexible decision tasks as well as
working memory tasks. Specific Aim 4 will be to study of neuromodulation and NMDA deficits of
this large-scale primate cortical model. Hypothesis: dopamine modulation displays a macroscopic
gradient along the cortical hierarchy, and impairment of NMDA receptors preferentially affects top-down
rather than bottom-up signaling in the global brain. Taken together, the proposed research will shed
fundamental insights into complex dynamics and cognitive functions in the global brain. It will also yield a
pioneering and powerful computational platform for basic research on large-scale brain systems of the
primates, as well as cross-level circuit mechanistic studies of psychiatric disorders like Schizophrenia.

Public health relevance
Project Narrative The proposed research aims at the development of a large-scale circuit model of the macaque monkey cortex capable of distributed working memory and rule-based flexible decisions, in collaborations with five top monkey experimental laboratories. A central idea is macroscopic gradients of circuit properties across the primate cortical hierarchy, including the strength of excitatory inputs, short-term plasticity and dopamine modulation. The proposed research will shed fundamental insights into complex dynamics and cognitive functions in the global brain, and yield an openly accessible computational platform for basic research as well as cross-level circuit mechanistic studies of psychiatric disorders.